DIAGNOSIS AND TREATMENT OF METABOLIC DISEASE--CLINICAL AND MOLECULAR

Patients with fructose intolerance, histidinemia, maple syrup urine disease, homocystinuria, organic acidurias and hyperammonemias are placed on special diets to omit or maintain low levels intake of those amino acids or their precursors whose accumulation in toxic levels results in severe neurological and mental derangements.